INTRACELLULAR SIGNALING IN ENDOCRINE CELLS

The mechanisms by which G protein-coupled and tyrosine kinase receptors control calcium signaling, and the physiological implications of such signaling, were investigated in several cell types. Three patterns of calcium signaling were observed: base-line oscillatory, with the frequency but not the amplitude of spiking controlled by agonist concentration; slow-oscillatory, with a constant frequency and variable amplitude of spiking; and non- oscillatory. The pattern of calcium signaling was not determined by the receptor subtype but by post-receptor events. Base-line calcium oscillations were initiated by injection of inositol trisphosphate (InsP3), as well as by exposure to compounds such as ionomycin, thapsigargin, and thimerosal. However, when the cytoplasmic oscillator was activated by these agents, it operated only at the basal rate of 5/min and its spiking frequency did not change with increasing drug concentrations, as commonly occurs in agonist-and InsP3-stimulated cells. In contrast, both types of oscillations were affected by the depletion of intra-luminal calcium and by changes in [Ca2+]i, but were not inhibited by ryanodine. The voltage-sensitive calcium entry pathway also affected InsP3- dependent calcium oscillations in excitable gonadotrophs. In agonist- and Insp3-stimulated cells, sustained calcium oscillations were extinguished by hyperpolarization after 3-15 min despite the availability of calcium in the extracellular medium. Single depolarizing pulses transiently restored the amplitude of the sustained spiking in a dihydropyridine- and extracellular calcium- sensitive manner. The responses to depolarization showed a marked dependence on membrane potential that was correlated with the steady-state inward calcium current. In addition, the repetitive application of brief depolarizing pulses modulated the frequency of agonist and InsP3-controlled spiking. These extrinsically driven and extracellular calcium-dependent oscillations were sensitive to the calcium-pump blocker, thapsigargin, but not to ryanodine. A mathematical model based on these experimental observations gave responses to a wide range of agonist doses, including the subthreshold responses, superthreshold base-line oscillatory response with frequency determined by [InsP3], biphasic oscillatory, and biphasic non-oscillatory response. The model also predicted the existence of non-receptor-mediated calcium oscillations. Calcium signaling is sufficient to trigger the expression of primary response genes (PROS) in several types of endocrine cells. In pituitary gonadotrophs, the protein kinase C- dependent induction of PROs was found to be modulated both positively and negatively by physiological changes in (Ca2+]i. Thus, the pattern of calcium signaling may represent an efficient mechanism for the control of gene expression in endocrine and other cell types.